Molecular analysis of genetic recombination and DNA break repair

Project Summary/Abstract
The long-term goal of the research proposed here is to determine the molecular mechanism of homologous
genetic recombination and DNA break repair. This objective is approached by a combination of genetic
analysis of mutants and biochemical analysis of proteins and DNA from cells. This research uses the fission
yeast Schizosaccharomyces pombe as well as the bacterium Escherichia coli and its phage lambda. All are
widely studied, highly tractable model organisms with features common to all organisms, including humans.
The studies are focused on meiotic recombination in S. pombe, whose high rates of recombination facilitate
both genetic and biochemical analyses, and on the major pathway of recombination and DNA break repair in
bacteria, promoted by RecBCD enzyme, a complex DNA repair machine, whose 3D structure allows us to
determine at atomic level how recombination initiation is regulated.
Building on past achievements, the research is currently focused on the following areas. 1) Studying
how meiotic DNA double-strand break (DSB) hotspots form clusters, and how these clusters impart DSB
interference and, consequently, crossover interference important for proper chromosome segregation. This
research promises to solve the 100-year-old problem of crossover interference, a major genetic puzzle for
which we have proposed a molecular mechanism and supported with many data. 2) Studying how RecBCD
enzyme controls its potentially rampant nuclease activity and appropriately activates it by interaction with Chi
hotspots of recombination (5’ GCTGGTGG 3’). This research promises to solve at near-atomic level the
molecular mechanism of RecBCD enzyme, the principal controller of the major pathway of E. coli
recombination, first observed 75 years ago, and a paradigm for chromosomal site control of other complex
DNA enzymes. 3) Seeking more potent RecBCD inhibitors, which are promising antibiotics against a novel
(unused) target. New antibiotics are needed to counter ever-more-frequent drug-resistant bacteria. These
goals will be attacked by a combination of genetic analysis of mutants, fluorescence microscopy of intracellular
proteins and chromosomal sites, physical analysis of DNA intermediates from meiotic cells, and enzymatic and
biophysical analyses of isolated proteins. The results of these studies will elucidate the molecular mechanism
of recombination and DNA break repair as well as the controls on recombination that ensure that it occurs at
the proper time and place along chromosomes.
Recombination is important for faithful meiotic chromosome segregation, error-free repair of frequently
arising DNA double-strand breaks, and generation of cellular and organismal diversity. Aberrancies of
recombination can generate chromosomal rearrangements, such as translocations, duplications, and deletions,
which are often associated with or the cause of infertility, birth defects, and cancers.

Public health relevance
Program Narrative (Relevance) The DNA of our cells is frequently broken and must be faithfully repaired for life to continue. Failure of faithful DNA break-repair by genetic recombination leads to birth defects, infertility, and cancer. Inhibitors of DNA break-repair in bacteria can be developed into novel, sorely needed antibiotics to combat the ever-threatening emergence of drug-resistant bacteria.